Examining the neuropsychiatric effects of HIV-1 integrase inhibitors

ABSTRACT
Approximately 1.2 million people in the US and ~ 37 million people worldwide are living with HIV-1. In
spite of considerable progress in HIV/AIDS research, anti-retroviral therapy (ART) remains the only treatment
option for HIV-1 infection. While ART has been highly effective in controlling the virus and making HIV infection
a manageable disease, the drugs used in the ART regimens cause adverse side effects. Among the most widely
prescribed antiretrovirals (ARVs) are integrase strand transfer inhibitors (INSTIs) which block the critical step of
HIV-1 integration into host chromosomes. Unfortunately, recent reports suggest association of INSTI prescription
with treatment-limiting neuropsychiatric adverse effects. Therefore, understanding the mechanisms that drive
neuropsychiatric effects of INSTIs are critically important for the long-term success of ART. The goal of this
proposal is to identify the mechanisms of INSTI-associated neuropsychiatric adverse events (NPAEs).
Currently, it is recommended that INSTIs be included in all initial regimens for HIV-1 treatment. the most
preferred ARVs. Currently approved INSTIs include raltegravir, elvitegravir, dolutegravir, bictegravir, and
cabotegravir. Although generally reported to be safe and effective there is a growing concern about the adverse
metabolic and neuropsychiatric effects associated with the INSTIs. We hypothesize that that INSTI-associated
NPAEs are driven by alterations in glutamate and calcium signaling that affect synaptic function and
neuronal communication in specific brain circuits. To test this, we propose three specific aims. In Aim 1, we
will e
lucidate the effects of HIV-1 INSTIs on glutamate neurotransmission. In
Aim 2, we will decipher
the
mechanism of INSTI-induced glutamate neurotransmission. In
Aim 3, we will probe the adverse effects of HIV-
1 INSTIs on neuropsychiatric circuitry. To achieve the goals of these specific aims, we have developed a novel
approach that combines the expertise in HIV neuropathogenesis, to that of neuroscience and neuropsychiatric
disorders and clinical research. Through this multidisciplinary approach, our studies will uncover novel cellular
and biochemical pathways that may be targeted to reduce INSTI-associated neuropsychiatric adverse effects.
HIV/AIDS disproportionally affects African-Americans and other minorities. ART is the only treatment
option available to reduce the disproportionate burden of this deadly disease. Unfortunately, long-term exposure
to ART contributes to treatment-limiting NPAEs among HIV-1 positive individuals. Given the rapidly expanding
global use of INSTIs to treat HIV, it is critical to understand the mechanisms that drive these NPAEs to reduce
the disproportionate impact of HIV/AIDS. Therefore, our proposed studies focused on HIV/AIDS are
perfectly aligned with the overall goals of the RCMI program.

Public health relevance
PROJECT NARRATIVE HIV-1 integrase strand transfer inhibitors (INSTIs) are among the most widely prescribed antiretrovirals. The goal of this application is to dissect the mechanism of INSTI--associated neuropsychiatric adverse effects. Our studies will generate new knowledge to promote novel strategies to prevent and/or manage INSTI- associated neuropsychiatric complications among people living with HIV.